Eval of Efficacy and Mechs of Anti-inflammatory Interven

Stomatitis is defined as inflammation of the mucous membranes of the oral cavity and oropharynx characterized by tissue erythema, edema, and atrophy, often progressing to ulceration. Stomatitis is a biologically complex, multifactorial, treatment-related oral condition experienced by many oncology patients, which often leads to a cascade of negative sequelae including oropharyngeal pain, critical treatment alterations or cessation, and decreased quality of life. The optimal treatment strategies for stomatitis have not been established. There is a critical need to examine the pathogenesis of and to evaluate interventions for stomatitis and related acute oropharyngeal pain in the randomized controlled clinical trial setting using valid and reliable stomatitis assessment tools to both advance the science of cancer treatment-related oral toxicities and improve patient care. Therefore, the purpose of this randomized controlled clinical trial is to elucidate the role of inflammation in stomatitis by testing the effects of a novel tumor necrosis factor (TNF) fusion protein etanercept, (Enbrel ?, Immunex Corporation, Seattle, WA) on the incidence and severity of stomatitis. The actions of this fusion protein, which binds specifically to TNF preventing its interaction with cellular receptors and altering the inflammatory cascade, may provide insight into the role of inflammation in stomatitis. An etanercept effect is defined as a prevention or amelioration of stomatitis and acute oropharyngeal pain and/or changes in levels of tissue mediators. If stomatitis is primarily a consequence of a mucosal inflammatory response, then we hypothesize that this oral condition will be responsive to binding of TNF-alpha. Elaboration of the role of inflammatory cell signalling associated with stomatitis and the effect of TNF-alpha may elucidate the mechanisms related to the pathogenesis of stomatitis and to other mucosal conditions.[unreadable] [unreadable] Patients who are scheduled to receive stomatogenic chemotherapy with autologous hematopoietic stem cell transplantation (HSCT), ages 16 years or older, will be invited to participate in this study during a regularly scheduled pre-treatment visit in the National Institute of Dental and Craniofacial Research Dental Clinic, or through established recruitment strategies at a National Cancer Institute sponsored Community Clinical Oncology Program located at the Cancer Centers of the Carolinas, Greenville, SC. Written informed consent will be obtained from all participants. Patients will be randomized to receive either etanercept mouthwash or placebo, which will both be administered by protocol schedule. Stomatitis and oropharyngeal pain will be measured at baseline and at specified post-chemotherapy time points corresponding with the predicted stomatitis onset, peak, and healing time course. TNF-alpha levels in buccal mucosa, analyzed by real time polymerase chain reaction techniques, and blood levels of pro-inflammatory cytokines, growth factors, and inflammatory mediators will also be measured at baseline and at specified post-chemotherapy time points corresponding with the predicted stomatitis onset, peak, and healing time course. The data and safety monitoring plan has been approved by the NINR Data and Safety Monitoring Board.[unreadable] [unreadable] The pilot study for this intervention study was designed to assess appropriateness of planned laboratory techniques to measure TNF-alpha in saliva, plasma, and buccal mucosa in this population, and to assess oropharyngeal pain in adult HSCT patients. Present overall intensity, worst intensity within 24 hours, sensory, and affective dimensions of oropharyngeal pain were assessed pre/post CT using the Oral Mucositis Assessment Scale and PainometerO. TNF-alpha concentrations were measured in saliva and plasma using ELISA, and in buccal mucosa using QPCR. Male and female subjects (N = 24), mean age 46 years, primarily Caucasian, with late stage cancer diagnoses, received one of five HCT protocols. Post-CT stomatitis was observed in 18 subjects (mean = 5.26); erythema (n=17) and ulcerations (n = 9). Subjects (n = 9) reported primarily continuous, mild overall intensity of oral pain (mean = 1.4), and higher pain levels on swallowing (n = 10) (mean = 2.38; range = 0 to 10). Stomatitis severity significantly positively correlated with oral pain overall intensity (p < .05), worst intensity (p < .001), and oral pain overall intensity and worst intensity with swallowing (p < .001). Pain with swallowing sensory descriptors included burning and sharp (23%); affective descriptors were annoying (2%), and miserable (18%). Ulceration significantly positively correlated with sensory pain (p < .05). Elevated post-CT salivary TNF-alpha concentrations compared with non-elevated plasma TNF-alpha levels (ELISA; R & D Systems, Inc., Minneapolis, MN) suggest a local inflammatory etiology of stomatitis. Buccal brush biopsy samples were processed by TRIzol only (TRI-O) (N = 46), and RLT-TRIzol (RLT-TRI) (N = 24). Real time PCR, employing complete controls and reference plasmids, for human TNF-alpha showed expression below detection threshold in the RLT-TRI group. Matched TRI-O samples showed mRNA copy numbers of 10^2 to 10^4, suggesting that TRI-O is the preferred method for buccal RNA. Buccal mucosa TNF-alpha expression ranged from 42 to 15300 copies. Fourteen subjects had measurable increases in TNF-alpha expression post CT via TRI-O method. Significant positive correlations were seen between TNF-alpha concentrations and pain dimensions: overall intensity (p < .05); worst intensity (p < .01); and overall (p < .05) and worst intensity with swallowing (p < .01).Validity of a unique, sensitive assay for gene expression from buccal brushing was demonstrated. These data demonstrate appropriateness of molecular techniques for this clinical trial.